Neuronal activity-dependent intracellular calcium signaling regulates oligodendrocyte maturation

PROJECT SUMMARY/ABSTRACT
Myelination is essential for information transfer and circuit function in the brain. New oligodendrocytes are
continuously generated throughout life, and recent studies showed that blocking the generation of new
oligodendrocytes disrupts learning and memory consolidation. Mature oligodendrocytes differentiate from
oligodendrocyte precursor cells (OPCs), a population of motile, proliferative precursors that tiles the CNS and
persists throughout life. OPCs receive direct synapses from neurons, and it has been hypothesized that they
integrate neuronal firing information to regulate their differentiation and myelination. Significant research has
been aimed at understanding the intracellular signaling pathways that regulate the maturation of
oligodendrocyte lineage cells (oligodendroglia), yet molecular mechanisms underlying neuronal activity-
dependent myelination are unknown. Furthermore, little is known about the excitation-transcription coupling
events that link extracellular neuronal stimulation with intracellular signaling dynamics and gene expression
changes in oligodendroglia. Activity-dependent changes in intracellular calcium drive myriad processes in
neurons related to synaptic plasticity and learning, yet the effects of calcium dynamics in OPCs have not been
carefully studied. Here, I will test the hypothesis that changes in neuronal activity modulate OPC calcium
release from intracellular stores to control their differentiation following learning. Aim 1 uses fast in vivo time
lapse imaging combined with viral expression of neurotoxins and holographic optogenetic stimulation to test
how manipulations in neuronal firing modulate OPC calcium signaling. Aim 2 combines in vitro molecular
biochemistry with longitudinal imaging and behavioral assays to assess if activity-dependent calcium release
from intracellular stores drives oligodendrogenesis. Results from these studies will provide essential insights
into the neuron-oligodendroglia interactions that govern myelin plasticity and may uncover novel therapeutic
targets for the treatment of demyelinating diseases.

Public health relevance
PROJECT NARRATIVE Multiple sclerosis affects at least 2.3 million people worldwide and is the most common demyelinating disease. While current MS treatments target the immune system to reduce future attacks, there is a major need for approved treatments that harness oligodendrogenesis to facilitate remyelination and repair. Results from these studies will provide essential insights into the intracellular mechanisms in oligodendgroglia that regulate activity-dependent myelination and may uncover novel therapeutic targets for the treatment of demyelinating and neuropsychiatric diseases.